Individual differences in dementia spousal caregiver burden: A biobehavioral approach

Project Summary/ Abstract
Caregiving for a spouse with Alzheimer’s Disease (AD) is one of the most stressful experiences a
person can encounter. Among married couples when one member of the dyad has AD, the disease is often
described as a relational illness because every aspect of the disease necessarily involves the spouse. Poor
quality of life (QOL) and caregiver burden characterize a significant proportion of AD spousal caregivers. AD
spousal caregivers also experience living bereavement as they experience profound feeling of grief analogous
to what one experiences when a spouse dies. The chronic stress of spousal AD caregiving magnifies age-
related changes in proinflammatory cytokines, an important predictor of morbidity and mortality.
Mechanistically, chronic stress promotes desensitization of glucocorticoid receptors promoting glucocorticoid
receptor resistance (GCR), which allows for elevated inflammation. Of course, not all AD spousal caregivers
are at the same level of risk. However, research attempting to identify which AD spousal caregivers are at
greatest risk is remarkably sparse. Out of the 173 studies examining the biological markers of physical health
in relation to AD spousal caregivers, there is no work, to our knowledge, that examines how relationship and/or
personality characteristics affect biological markers of physical health. Determining stable individual difference
characteristics is critical to developing evidence-based treatments. Attachment theory is a useful framework for
understanding individual differences in close relationships as well as how people cope with stressful life
events. There are two patterns of attachment insecurity: attachment anxiety and attachment avoidance. People
with high attachment anxiety use "hyperactivating" emotional coping strategies that accentuate the stress
response. People with high attachment avoidance are uncomfortable depending on others and use
"deactivating" coping strategies in an attempt to inhibit stress. This investigatory team demonstrated that
compared with bereaved adults with low attachment anxiety, recently bereaved adults with higher attachment
anxiety experienced more grief, more depressive symptoms, and elevated inflammation. Those who reported
more grief had elevated levels of inflammation compared with those who reported less grief. Likewise, those
who reported poorer QOL had higher levels of inflammation than those who reported better QOL. Our pilot
work in AD spousal caregivers echoes these findings. We have also demonstrated that the association
between attachment avoidance and health outcomes is moderated by high heart rate variability (HF-HRV), an
important marker of aging, and emotion regulation (HF-HRV). We build upon our findings in bereaved adults to
advance our understanding of which AD spousal caregivers are most vulnerable to the deleterious physical
health effects of spousal dementia caregiving as they navigate the experience of living bereavement, while
coping with the burden of caregiving and trying to maintain QOL. As an exploratory aim, we will examine how
these individual differences in attachment orientation affect both members of the marital relationship.

Public health relevance
Project Narrative By understanding how individual differences in relationship/personality characteristics predict biological markers of mental and physical health, intervention scientists will be better able to identify at-risk AD spousal caregivers. Attachment orientations could contribute to treatment planning; our current lack of knowledge regarding who is most at risk for immune dysregulation severely hampers our conceptual models and ability to develop evidenced interventions.